Young Investigators Career Science and Mentoring Program (R13)

? DESCRIPTION (provided by applicant): This program provides investigators with tools to obtain funding necessary to carry out clinical research to improve the diagnosis and treatment of individuals with musculoskeletal diseases. The national impact of this young investigators research will be appreciated by musculoskeletal disease patients who will be diagnosed sooner and treated more effectively. Their quality of life will be improved from novel clinical research studies performed by the young investigators in these workshops.

Public health relevance
PUBLIC HEALTH RELEVANCE: The burdening of musculoskeletal diseases in the United States is growing rapidly due to the aging population. This program provides junior clinical musculoskeletal researchers with tools to obtain peer-reviewed funding in the musculoskeletal fields, and pursue research that will improve the both the diagnosis and treatment of these diseases.